Phantom and Automated Analysis for Advanced Computed Tomography Systems

PHANTOM AND AUTOMATED ANALYSIS FOR ADVANCED COMPUTED TOMOGRAPHY SYSTEMS
Abstract
This application is a supplement application to U01 EB034205-01, “Multiple x-ray source array
(MXA) computed tomography”. The Corgi phantom is an image quality and radiation dosimetry
phantom designed specifically for CT scanners and cone beam CT systems and is sold
commercially by the Phantom Laboratory. A key component to this physical phantom is analysis
software which will automatically generate rigorous image quality metrics such as the
modulation transfer function, the noise power spectrum, linearity, spatial uniformity, and cupping
artifact – automatic assessment is performed by uploading the DICOM CT information to the
Phantom Laboratory website. Aim 1 of this proposal is to add an additional module to the
existing modular Corgi phantom, which contains signals which allow the assessment of both
volume and texture. Volume accuracy is important in cancer imaging (etc.), and texture analysis
is important to the growing field of CT radiomics. Aim 2 of this proposal will make use of the
existing Corgi capabilities in addition to the new capabilities to assess the development of the
MXA-CT scanner prototype which is the subject of the parent award. Aim 3 of the proposal will
be to develop a user group of CT physicists around the country who will use the infrastructure
created by the NIST/NIBIB Phantom Lending Library to access both the Corgi phantom and the
evaluation software and evaluate unique CT scanner technologies at their institutions. The user
group will be able to assess and perhaps improve the infrastructure at the Phantom Lending
Library, in recognition that this phantom includes both hardware and software licensure
requirements. Overall, the proposed research will result in an improved Corgi phantom capable
of rigorous and quantitative assessment of CT scanner performance. It will be useful to
researchers developing new hardware or reconstruction software for CT, and it will also be very
useful to clinical medical physicists as they survey CT scanners at their institutions. The
comprehensive set of quantitative metrics, combined with the ease of use and reproducibility of
the assessment software, will improve CT performance evaluation and help to standardize the
metrics for CT image quality performance.

Public health relevance
PHANTOM AND AUTOMATED ANALYSIS FOR ADVANCED COMPUTED TOMOGRAPHY SYSTEMS Narrative This application is a supplement application to U01 EB034205-01, “Multiple x-ray source array (MXA) computed tomography”. In this proposal, the existing modular CT image quality phantom (called “Corgi”, produced commercially by the Phantom Laboratory) will be upgraded to include an additional module which includes the ability for automated analysis for both volume and texture accuracy, as well as software upgrades to include task-based model observer performance. The supplemental application will also address how these updates to the Corgi phantom will impact our assessment of the prototype CT scanner produced in the parent award and will also develop the users group to assess the utility of the new phantom module, the accompanying software analysis tools available online, and the NIST/NIBIB Phantom lending library infrastructure.